Administrative Core

PROJECT SUMMARY/ABSTRACT
The Administrative Core will provide a strong infrastructure as well as administrative and logistical support to
ensure timely implementation of all Projects, Core activities, and cross-project collaborative opportunities for the
CANOE Partnership: Cancer Awareness, Navigation, Outreach, and Equitable Indigenous Health Outcomes.
The three Projects will have geographic diversity, which adds to the complexity of the overall U19 proposal and
requires the experienced Administrative Core leadership team to ensure application of the Indigenous Cancer
Health Equity-Initiative (ICHE-i) Model in the design and implementation of Projects and Cores. They will also
implement the overall evaluation plan using the Indigenous Evaluation Framework. The Administrative Core
leaders, Drs. Lonnie Nelson, Myra Parker, and Jason “Jay” Mendoza are the MPIs of the CANOE Partnership
and have extensive experience leading research projects with Indigenous populations and applying CBPR
approaches in their work. The Specific Aims include:
1) Design and support the overall program structure and goals using the ICHE-i Model, which centers
relationality, a holistic approach, and sustainability in support of Tribal Sovereignty as integral to TribalAcademic research partnerships.
2) Apply an Indigenous Evaluation Framework to assess program milestones and outcomes using a mixed
methods approach that triangulates quantitative and qualitative data. The Framework will inform tracking of
Project and Core milestones and evaluations; bidirectionality of equitable research processes; and collection
of Indigenous Success Measures as empirical, revealed, and traditional knowledge types.
3) Facilitate and harmonize the use of common data elements across research projects and provide a
biostatistical resource to conduct each Project’s data analyses. We will use a collection of tools extracted
from the PhenX Toolkit to assess social determinants of health (SDOH) and other predictors of Project
outcomes across all CANOE Partnership Projects and data collection activities. Where needed, measures
will undergo cultural adaptation for Indigenous populations using a process that considers eight dimensions
of culture.
Impact: The Administrative Core will be led by three experienced MPIs who are supported by key staff leaders
with substantial expertise administering research grants as collaborations with AI/AN participants. Altogether
they will lead an efficient operations and oversight infrastructure that will enable the Research Project
investigators, staff, and Tribal Organizations/Tribes to equitably and bidirectionally implement the three proposed
Research Projects to address cancer inequities nationally (smoking cessation) and in our Washington state
catchment area (lung, breast, and colorectal cancer screenings and HPV vaccinations).